Anatomy

The goal of the anatomy core is to provide support, services and data that will lead to the timely completion of individual project aims. The data collected by Center investigators comes from a wide range of sources including studies of rodents, primates and humans. One of the major aims of the Center will be to broaden our understanding of the functional neuroanatomy of the orbital and medial prefrontal cortical networks. The overall mission of the anatomy core is to provide the bridge between projects to identify structures that are likely to be affected by HFS across species. To achieve this goal, the anatomy core will work closely with each of the individual projects and the Informatics Core, to develop cross-species models of structures and pathways. The anatomy core will also provide resources and service to projects that require routine anatomical analysis. A major aim of core B is to develop a model of cortical fibers in rodents and link that circuitry to the results from P4,5,6 that examine behavioral and physiological mechanisms underlying changes following DBS to. Core B will develop a 3-D atlas of the fiber bundles derived from frontal cortex that travel, through the striatum to the thalamus in the rat. This information will be used with the monkey and human anatomy (P2) in Core C to address how the region of stimulation in P4-5 might relate to homologous areas in primates (P3) and humans (PI). In addition. Core B will provide resources and service to projects that require anatomical analysis (P,4,5), including cell counts for c-Fos and p-Erk activation (P4,5,), and 3-D reconstructions of stimulation and recording sites for P,4,5. RELEVANCE (See instructions): Obsessive Compulsive Disorder (OCD) is a chronic psychiatric illness that affects 2-3% of the worldwide population. This is disease is in the top ten dehabilitating diseases. This study will examine the neural network and mechanisms that underlie behaviors associated with OCD. These behaviors not limited to OCD, but are associated with a range of affective and addictive disorders. The collective proposed studies will generate new hypotheses of how dysfunctions within these brain networks are expressed across diseases and provide insight into the mechanisms underlying normal behavioral responses.

Public health relevance
Obsessive Compulsive Disorder (OCD) is a chronic psychiatric illness that affects 2-3% of the worldwide population. This is disease is in the top ten dehabilitating diseases. This study will examine the neural network and mechanisms that underlie behaviors associated with OCD. These behaviors not limited to OCD, but are associated with a range of affective and addictive disorders. The collective proposed studies will generate new hypotheses of how dysfunctions within these brain networks are expressed across diseases and provide insight into the mechanisms underlying normal behavioral responses.